The role of heme in the oxidative modification of mRNA

PROJECT ABSTRACT
RNA oxidation is a hallmark of neurodegeneration, and may contribute to the altered gene expression seen in
neurodegenerative disease. The major oxidative modification is 8-hydroxyguanosine (8-OHG), which impairs
translation and other aspects of RNA function. Reactive oxygen species (ROS), generated by mitochondria
through cellular respiration, are the drivers of RNA oxidation. Although ROS is generally thought to
nonspecifically modify nucleic acids, microarray analysis of 8-OHG-containing mRNA from Alzheimer's patient
samples found that only certain mRNAs underwent oxidation. However, it is currently unclear how ROS can
selectively modify specific mRNA. To understand the basis for selective RNA oxidation, I performed an 8-OHG
mapping study using antibodies that bind 8-OHG. I found that these antibodies bind to regions which appear to
correspond to G-quadruplexes. In vitro studies previously showed that G-quadruplexes can bind heme,
converting heme into a highly efficient ROS generator. Based on these prior studies, I asked if heme can bind
to cellular mRNA. I developed Heme-seq, a method for mapping heme-binding sites in mRNA, and found that
heme-binding sequences are found throughout the transcriptome and correspond to G-quadruplex regions.
Additionally, I developed 8-OHG-seq, a new single-nucleotide 8-OHG mapping method, which shows 8-OHG
enrichment in G-rich regions consistent with G-quadruplexes. My 8-OHG mapping data supports the idea that
8-OHG is a selective modification. Furthermore, my data suggest that heme binds to G-quadruplex sequences
in cellular mRNA, leading to localized ROS generation and RNA oxidation. In order to test this hypothesis, the
aims of this project are: Aim 1: To determine the role of heme-binding events on 8-OHG formation in mRNA. I
will use small molecules that displace heme from G-quadruplexes to determine if heme must directly contact
G-quadruplexes in RNA to catalyze 8-OHG formation. I found that cell stress leads to increased heme binding.
I will determine if this increased binding occurs at G-quadruplexes and is associated with formation of new 8-
OHG sites. These experiments will address whether heme-binding to G-quadruplexes is the mechanism of
specificity for RNA oxidation. Aim 2: To determine the role of cell stress on the folding of heme-binding sites.
Cell stress markedly increases the folding of G-quadruplexes in cells. I will map the location of endogenous
heme-binding sites induced by serum deprivation and determine if these sequences are G-quadruplexes that
fold in response to stress. These aims will provide insights into the role of heme-binding to RNA as a
mechanism in RNA oxidation. These studies will also allow me to achieve training goals related to acquiring
knowledge and skills in RNA biology, molecular mechanisms related to neurodegeneration, and developing
bioinformatic skills, which will help me develop the skills to become an independent investigator.

Public health relevance
PROJECT NARRATIVE RNA oxidation is a hallmark of neurodegeneration that impairs translation and other functions of RNA. Heme is an endogenous small molecule that can bind to mRNA and catalyze RNA oxidation. These studies will determine whether heme binding directs the formation of oxidative modifications in mRNA and whether cell stress changes the folding of heme-binding sites in mRNA.